Targeting posttranslational modifications of CD73 in TNBCs

Targeting posttranslational modification of CD73 in TNBC
The goal of this project is to determine the impact of proteolytic regulation of CD73 by the E3 ligase TRIM21 in
breast carcinogenesis and as a therapeutic target in breast cancer. CD73 is a multifunctional ectoenzyme
affecting both tumor cells and immune cells. Elevated tumor expression of CD73 is tightly correlated to poor
prognosis in various types of cancers, especially triple-negative breast cancer (TNBC). Furthermore, abnormal
accumulation of CD73 is thought to interfere with both chemotherapy and immunotherapy, and contribute to
tumor evasion/progression/metastasis and drug resistance. It is unclear whether the pathological accumulation
of CD73 in TNBC is caused by impaired regulation of protein turnover. We recently purified the CD73 protein
complex, which led to the identification of TRIM21 as a ubiquitin E3 ligase that governs CD73 ubiquitylation and
degradation. We found that TRIM21-facilitated proteolysis of CD73 determines an abundance threshold above
which adenosine signal-mediated T cell proliferation and activity regulates tumor invasion. In co-cultures of
TNBC cells and activated CD8+ T cells, depletion of TRIM21 or stabilization of CD73 in TNBC cells led to
elevation of adenosine in the tumor microenvironment, resulting in significant suppression of T cell expansion
and enhanced T cell exhaustion. We further demonstrated that disruption of TRIM21-mediated CD73
ubiquitylation in a preclinical animal model led to tumor progression associated with an increase in adenosine
signaling by the tumor and inhibition of T cell proliferation/function. These data suggest that TRIM21 is a critical
player that determines CD73-mediated tumor evasion and invasion, and that manipulation of CD73 turnover may
be a novel therapeutic strategy that could be combined with current FDA-approved TNBC treatment regimens.
In this proposal, we aim to determine the pathophysiological role of CD73 ubiquitylation by TRIM21 in TNBC
progression through modulation of tumor immunity, and to examine the clinical relevance of the TRIM21-CD73
axis in TNBC therapy. We will test the hypothesis that loss of TRIM21-mediated CD73 degradation affects
tumor immunity to promote TNBC tumor evasion/progression and inhibit cancer therapeutic efficacy, and that
modulating the TRIM21-CD73 axis will reverse these processes in TNBC. We propose the following specific
aims to test this hypothesis: (1) Determine the mechanism by which TRIM21 regulates CD73-mediated tumor
immunity; (2) Determine the physiological relevance of CD73 ubiquitylation by TRIM21 in regulating tumor
immunity; and (3) Determine the relevance of the TRIM21-CD73 axis in anti-TNBC treatment in various
preclinical animal models.

Public health relevance
Project Narrative: Results from recent TCGA and pathological studies imply the oncogenic role for CD73 in breast tumor evasion and progression, although the underlying molecular mechanisms by which dysregulation of CD73 by ubiquitin-proteasome pathway contributes to breast tumor evasion, progression and metastasis remain unknown. This proposal will determine the impact of CD74 proteolytic regulation by TRIM21 in breast carcinogenesis, and further determine the clinical relevance of modulation of CD73 turnover regulation in anti-breast cancer treatment, especially for triple negative type breast cancers. Completion of this project will uncover the molecular underling of CD73 ubiquitination by TRIM21 in breast carcinogenesis and tumor microenvironment, and could provide a new strategy for breast cancer therapy by targeting TRIM21-CD73 axis.